Maternal obesity depresses essential fatty acid transport in the placenta

Project Abstract The candidate's five-year career goal is to become an independent investigator in the areas of maternal nutrition and placental nutrient transport and metabolism. Her long-term career objective is to build a strong translational research program, utilizing appropriate animal models and human investigations to study the effect of maternal pre-pregnancy nutrition on placental growth and function, neonatal health, and the offspring's risk of future cardiovascular disease. It is becoming increasingly clear that the placenta plays a key role in the origin of adverse fetal outcomes resulting from maternal over- or under-nutrition. In keeping with this view, the placenta is an important element in the origins of adult chronic disease. The candidate has a strong scientific background in molecular biology, immunohistochemistry, primary cell culture and small and large animal surgery. She has gained expertise in fetal physiology (especially of the cardiovascular system) and is well-versed in the literature surrounding the developmental origins of health and cardiovascular disease. Additional training is required however before she can achieve her career goal of becoming an independent investigator in maternal-fetal health. The proposed training program has been designed to provide: 1) training in placental physiology and research methodologies, 2) experience in nutritional science and research methodologies and 3) in-depth training in human investigation. The Oregon Health and Science University is an ideal environment for this training. It offers its strong reputation as a leading biomedical research and training institution; the Heart Research Center is internationally recognized for its work in fetal physiology and the developmental origins of health and disease; the Oregon National Primate Research Center is internationally recognized for its translational research in pregnancy and the Oregon Clinical and Translational Research Institute is dedicated to the development of successful trainees and young investigators in translational and clinical research. One in five women who deliver in the United States is obese (body mass index (BMI) of >30 kg/m2). This condition is associated with both short- and long-term adverse consequences for mother and her baby. Such babies are at risk for developing chronic diseases including adult-onset coronary heart disease and the metabolic syndrome. Our preliminary data show that male offspring of overweight and obese mothers have lower levels of docosaehexanoic acid - a long chain polyunsaturated (LC-PUFA) derivative of essential fatty acids - than female offspring, while no differences in LC-PUFA levels exist between male and female offspring of lean women. Such deficiencies lead to neurological and vascular pathologies in the newborn. All of the essential LC-PUFA that are acquired by the fetus are actively transported across the placental barrier. The effect of maternal obesity on placental delivery of LC-PUFA to the fetus is unknown. Due to their rapid growth in utero, boys invest less in placental growth than girls and are at a greater risk of undernourishment and poor outcomes in response to stressful conditions. Maternal obesity exposes the placental-fetal unit to pro-inflammatory molecules. Inflammatory cytokines inhibit fatty acid uptake in the liver, muscle and heart. The effect of inflammatory cytokines on placental transport is not known. It is also unknown whether male fetuses and their placentas are more sensitive than females to maternal obesity and inflammation. The overall goal of this proposal is to determine the degree to which maternal obesity alters gender-specific fatty acid transport in the placenta. Studies will be conducted in our non-human primate model of maternal obesity from which we will establish the relationship between obesity and 3rd trimester placental fatty acid transport in vivo using stable isotope-labeled fatty acid tracers. Complementary studies in women will determine the degree to which maternal BMI and fetal sex alter placental lipid uptake. The roles of inflammatory cytokines in altering fatty acid uptake kinetics will be determined in placental tissue isolated from lean women with male or female offspring. These translational studies will determine the effect of maternal obesity, fetal sex and inflammatory cytokines on placental fat transport in a human population. Upon completion of the proposed studies, we will have determined 1) the degree to which maternal obesity alters uptake and transport of LC-PUFA in the late gestation non-human primate placenta, 2) the effect of fetal gender on placental LC-PUFA uptake in women at term and 3) mechanisms by which inflammatory cytokines suppress placental fatty acid uptake in vitro.

Public health relevance
Project Narrative The prevalence of obesity in women who give birth in the US is 1 in 5, which is associated with severe health consequences for both mother and child. Poor fetal nutrition during development due to maternal obesity is known to put the child at a higher risk of cardiovascular disease in later life. The proposed studies will help us understand how obesity during pregnancy alters the placental transfer of nutrients from mother to child and how this impacts neonatal nutrition. __SpecificAimsTextDelimiter__ 10. Specific Aims The burgeoning obesity epidemic is yielding increasing numbers of babies who are faced with long term consequences of a stressful in utero environment. One woman in five who gives birth in the US is obese (body mass index (BMI) >30 kg/m2), a condition associated with higher health care costs, greater incidence of maternal and fetal complications during pregnancy and poor neonatal outcomes - including perinatal death. Children born to obese mothers are at a high risk for acquiring cardiovascular disease in later life. Owing to an aggressive growth strategy in utero, boys are especially sensitive to maternal nutrition and more of them die during the perinatal period. Our preliminary data show that male offspring of overweight and obese mothers have lower levels of docosaehexanoic acid (DHA, 22:6 n-3) - a long chain polyunsaturated (LC-PUFA) derivative of essential fatty acids - than female offspring, while no differences in LC-PUFA levels exist between male and female offspring of lean women. LC-PUFA, particularly of the n-3 variety, are essential for neurological and vascular development and have anti- inflammatory and anti-oxidant properties which protect against the development of cardiovascular disease in adulthood. The ability of the fetus to synthesize LC-PUFA from dietary essential fatty acids is limited; thus the fetus depends upon the placenta for its supply. The effect of maternal obesity on placental delivery of LC-PUFA to the fetus is unknown. Due to their rapid growth in utero, boys invest less in placental growth than girls and are at a greater risk of undernourishment and poor outcomes in response to stressful conditions. Maternal obesity exposes the placental- fetal unit to pro-inflammatory molecules. Inflammatory cytokines inhibit fatty acid uptake in the liver, muscle and heart. The effect of inflammatory cytokines on placental transport is not known. It is also unknown whether male fetuses and their placentas are more sensitive than females to maternal obesity and inflammation. Scientists at OHSU have developed a model of diet-induced maternal obesity in the Japanese macaque non- human primate (NHP). The offspring of obese pregnant monkeys are hyperlipidemic, have elevated circulating pro- inflammatory cytokines and develop blatant fatty livers in the early third trimester (130 days of gestation) and increased adiposity as juveniles. The NHP serves as an excellent model to study the effects of maternal obesity on placental function and fetal development. We propose to investigate fatty acid transport in vivo and in vitro in late gestation obese monkeys. In addition, translational studies will be conducted in women at term to determine if fetal sex plays a role in the relationship between maternal pre-pregnancy BMI and placental fatty acid uptake. We hypothesize that maternal obesity is associated with suppression of fatty acid transport within the male placenta which is mediated by a keen sensitivity to inflammatory cytokines. If present, the resulting deficiency in LC- PUFA would place the male offspring of obese mothers at an elevated risk of cardiovascular disease later in life. Overall Aim: To determine the degree to which maternal obesity alters gender-specific fatty acid transport in the placenta. The Specific Aims of this proposal are as follows: 1. To determine the degree to which maternal obesity alters uptake and transport of LC-PUFA in vitro and in vivo in the late gestation NHP placenta. We hypothesize that the transfer of the LC-PUFA AA and DHA from the obese mother to the fetus will be suppressed due to decreased uptake.1a) The placental transfer of 13C-labeled arachidonic acid (AA, 20:4 n-6), DHA, oleic acid (18:1) and stearic acid (18:0) will be quantified in vivo at 130d gestation. 1b) Placental fatty acid uptake and gene expression of placental fatty acid transporters (ie. FAT/CD36, FABP, FATP) will be measured at 130d gestation in placental explants in vitro. 2. To determine the effect of fetal gender on placental LC-PUFA uptake in women at term. We hypothesize that placental LC-PUFA uptake will be decreased with increasing maternal BMI in male fetuses but not female fetuses. Placental LC-PUFA uptake kinetics and expression of fatty acid transporters will be quantified in vitro in explants from term male and female placentas across a range of maternal pre-pregnancy BMI. 3. To determine the mechanisms by which inflammatory cytokines suppress placental fatty acid uptake in vitro. We hypothesize that placental LC-PUFA uptake will be suppressed by inflammatory cytokine treatment specifically in male placentas and that this effect is mediated by inhibition of the cellular energy sensor, AMPK. 3a) We will quantify, in vitro, the effects of inflammatory cytokines (i.e. tumor necrosis factor-α, interleukin (IL)-1β, IL-8, C- reactive protein) on fatty acid uptake and activity of upstream regulators of fatty acid transport and metabolism (i.e. AMP-activated protein kinase (AMPK), peroxisomal proliferator-activated receptor (PPAR) ¿ and ¿) in placental explants cultured from male and female term placentas. 3b) The AMPK inhibitor compound C will be used to assess the role of the energy sensor AMPK in cytokine-inhibited fatty acid uptake. These studies will extend the in vivo and in vitro data obtained in Specific Aims 1 & 2 to establish mechanisms regulating gender-sensitive LC-PUFA transport to the fetus.